Plasma Membrane Targeting and Retargeting of Polarity Proteins

SUMMARY
Targeting polarity proteins to mutually exclusive plasma membrane (PM) domains is an essential
process for establishing and maintaining cell polarity – a process that is regulated by an ever-expanding
interaction network among polarity proteins and their regulators/effectors. In contrast, much less is known
about how physical interactions between polarity proteins and the PM contribute to this polarization process.
Recent research from the PI’s lab showed that multiple core polarity proteins (“polybasic polarity proteins”)
such as Lgl, aPKC, and Dlg are also inherently membrane-binding proteins. They contain so-called polybasic
domains that specifically and electrostatically target to the PM by binding to PM phospholipids such as PI4P
and PIP2. We have characterized multiple mechanisms that control the polarized electrostatic PM targeting
function of polybasic polarity proteins. We have also discovered an unexpected consequence of such widely
existing electrostatic PM targeting in cell polarity: PM localization of polybasic polarity proteins is highly
susceptible to energetic stresses triggered by hypoxia and ATP inhibition, which induce dynamic turnover of
PM PI4P and PIP2. In this proposal, our goal is to further establish electrostatic PM-targeting as a fundamental
mechanism regulating cell polarity under both normal and energetic stressed conditions. Specifically, we will
investigate:
1) Diverse mechanisms regulating electrostatic PM targeting in cell polarity. We will focus on the
regulation of electrostatic PM targeting of basolateral polarity protein Dlg which is controlled by
phosphorylation, allosteric regulation of its polybasic domain, and interactions with other basolateral polarity
proteins. We will elucidate how allosteric regulation of electrostatic PM targeting acts as a core mechanism by
which basolateral polarity proteins control each other’s localization and functions.
2) Control of aPKC phosphorylation by electrostatic PM targeting. aPKC is the key kinase driving cell
polarization and its pseudo-substrate region (PSr) is also a polybasic domain that is allosterically controlled by
Par-6 for both PM targeting and kinase activity. Using a novel inducible polarization system, we will investigate
the hypothesis that Par-6-dependent electrostatic PM targeting of aPKC controls the substrate-specific
phosphorylation of aPKC/Par-6, providing a mechanism of spatiotemporal control of aPKC kinase activity in
cell polarization.
3) Regulation of electrostatic PM retargeting of polybasic polarity proteins. Despite total loss of the PM
targeting function of Lgl and aPKC under hypoxia due to depletion of PM PI4P and PIP2, we found that both
proteins always directly retargeted their original basolateral or apical PM domains once reoxygenation started.
We will investigate both lipid- and protein-based mechanisms that restore and control such polarized PM
retargeting of polybasic polarity proteins. These mechanisms will be critical to our understanding of how cell
polarity survives energetic stress conditions such as hypoxia and ischemia.
Our proposed research will delineate essential molecular details that integrate electrostatic PM
targeting into the regulatory network of polarity proteins and phospholipids. Discovering novel mechanisms
regulating electrostatic PM targeting will be fundamental to our knowledge on cell polarity under both normal
and stress conditions.

Public health relevance
Project Narrative: Establishing and maintaining cell polarity is essential for cell function and tissue integrity, whereas the disruption of cell polarity is often linked to tumorigenesis and injury under ischemia. In this proposal, we focus on a novel mechanism based on the newly discovered electrostatic interaction between polarity proteins and plasma membrane (PM) phosphoinositides. Electrostatic PM targeting acts as an integral mechanism that not only regulates the subcellular localization of polarity proteins, but also directly controls their polarity functions. Our research will facilitate the analysis and treatment of diseases such as ischemia and cancer by understanding how polarity may be established, maintained, and restored under normal and pathological conditions, including hypoxia, ischemia, and tumorigenesis.